Novel Mechanisms of Nuclear Phosphoinositide Signaling in Regulation of the YAP/TAZ Pathway in Triple-negative Breast Cancer

Phosphoinositides (PIs) are lipid messengers that control many aspects of human physiology. A significant
fraction of PIs (>40% of total PIs) is found in the nucleus, however the nature and functions of the nuclear
PIs are largely unknown. We discovered that phosphatidylinositol 4,5-bisphosphate (PI4,5P2) is an
abundant PI species in the nucleus and the PI4,5P2-generating kinase phosphatidylinositol-4-phosphate-5-
kinase type 1 alpha (PIPKI􀁄) is a major enzyme modulating nuclear PI4,5P2 signaling. Nuclear PI4,5P2 can
be further phosphorylated by a nuclear-localizing PI3-kinase (PI3K) inositol phosphate multikinase (IPMK)
to produce a PI species, PI3,4,5P3, that has been implicated in oncogenesis. This suggests that PIPKI􀁄
and IPMK are potential targets for cancer therapy. Consistently, we showed that depletion or
pharmacological inhibition of PIPKI􀁄 and IPMK leads to cancer cell death by apoptosis in triple negative
breast cancer (TNBC) cells. Moreover, in TNBC cells, we discovered that depletion of PIPKI􀁄 and IPMK
significantly reduces the expression of YAP/TAZ target genes that have established contributions to
oncogenesis. TNBC is the most aggressive subtype of breast cancer and associated with poor patient
survival due to lack of alternatives to current chemotherapies. As a result, there is an urgent need for
discovering novel targeted therapeutics in TNBC. The YAP/TAZ-PI kinases (PIPKI􀁄 and IPMK) pathways
are attractive drug targets because aberrant activation of YAP/TAZ is frequently found in breast cancer
particularly in TNBC, PIPKI􀁄 gene is commonly amplified in TNBC, and the nuclear PI3,4,5P3 pathway is
frequently deregulated in TNBC. Precise understanding of nuclear PIs-mediated YAP/TAZ pathway will
provide knowledge which can be utilized for developing targeted therapeutics against TNBC. In this
proposal, we will 1) elucidate molecular mechanisms by which the YAP/TAZ pathway is controlled by
PIPIK􀁄 and IPMK via extensive biochemical and cell biological approaches and 2) investigate contributions
of PIPIK􀁄 and IPMK in TNBC pathogenesis in cultured TNBC cells and mouse models.

Public health relevance
Triple-negative breast cancer (TNBC) is the most aggressive subtype of breast cancer and has limited therapeutic options, pointing out an urgent need to identify novel targets and develop targeted therapeutics for TNBC treatment. Here we provide compelling evidence that the lipid messengers called phosphoinositides are critical for gene expression which promotes TNBC progression. In these proposed studies we will validate proteins that are responsible for producing phosphoinositides are promising druggable targets in TNBC and this will provide novel methods for the development of therapeutics against TNBC.